Unbiased electrothermal flow-enhanced identification of antigen-specific T cells in lung cancer

Project Abstract/Summary
Despite their success, immunotherapies fail to engage T cells on an antigen-dependent basis rather opting to
reactivate a broad spectrum of T cells of unknown specificity based on their location or phenotype. Markers such
as PD-1 have been posited to delineate anti-tumor T cells but are also expressed on those recognizing non-
tumor antigens. Likewise, tumor-resident T cells are surmised to exhibit tumor antigen recognition though they
have been shown by us and others to also recognize viral and bacterial antigens (ie. bystander T cells). MHC
multimers present a potent alternative to identify anti-tumor T cells but are limited by a need for anterior
identification of the antigen(s) of interest. This limitation is compounded by a lack of understanding of the antigens
that are immunogenic and the T cells that recognize them. Recent discoveries into the impact of tumor mutational
burden (TMB) have bolstered our grasp of the origins of tumor antigens, despite TMB failing to consistently
predict clinical outcomes. This is perhaps best epitomized by the dismal antigen validation rates which hover at
~1%. Hence, our understanding of which T cells exhibit therapeutic anti-tumor potential in solid tumors
remains problematic. Therefore, there is a critical need for unbiased approaches capable of identifying anti-
tumor T cell responses, a lack of which will substantially impede the progress of immunotherapies in solid tumors.
We previously developed ATTACH (Assessment of T cells Tethered to Antigen Class I/II Histocompatibility), a
powerful microfluidics assay which allows direct isolation of anti-tumor T cells by leveraging HLA/peptide binding
avidity of T cell receptors (TCR) to matched tumor cells serving as de facto “tetramer pools”. Here, we propose
the development of an ATTACHER (ATTACH via Electrothermal flow-enhanced Recovery), a microfluidic device
capable of streamlining this assay while increasing sensitivity, specificity, and antigen-specific T cell recovery.
Our central hypothesis is that T cells recognizing multiple tumor antigens can be directly isolated in vitro using
a T cell ATTACHER, and that these cells harbor increased anti-tumor cytotoxic potential compared to bulk T
cells. We have formulated this hypothesis on the basis of preliminary studies outlining the ability of ATTACH to
enrich for tumor-infiltrating lymphocytes (TILs) with increased cytotoxic potential. The rationale for the proposed
research is that applying electrothermal flow to ATTACH via development of a T cell ATTACHER will promote T
cell/tumor cell contact and allow T cells to scan multiple MHC/antigen complexes in order to encounter their
cognate antigen. In Aim 1, we will design and construct the T cell ATTACHER and evaluate its ability to recover
antigen-specific T cells across a set of 20 different human antigens and TCRs of different affinities developed in
our lab. In Aim 2, we will characterize TILs isolated using the T cell ATTACHER both phenotypically and
functionally using paired human patient-derived xenografts and tumor-infiltrating lymphocytes from the ICON
cohort. We anticipate our work will allow us to demonstrate the versatility of the T cell ATTACHER and its ability
to improve anti-tumor responses in vitro. Overall, our work will allow direct, accurate and unbiased identification
of anti-tumor T cells in solid tumors within hours rather than months as is currently required, laying the
foundation for subsequent studies into the predictive and therapeutic potential of this method in solid tumors.

Public health relevance
Project Narrative T cells are highly effective at destroying cancer cells based on the antigens they display but our understanding of which T cells destroy tumors and which antigens enable them to do so is rudimentary. Current approaches to decipher these questions rely on challenging experimental procedures which are costly, labor-intensive, exhibit a low success rate and can take months to perform, impacting their clinical applicability. Our novel device overcomes these hurdles, allowing the direct identification and isolation of anti-tumor T cells within only hours thereby improving potential applicability to the treatment of solid tumors.